HIV Reservoir and Gene Modified Cell Dynamics Following Autologous Stem Cell Transplantation

SUMMARY/ABSTRACT: The use of autologous gene modified cells that are resistant to HIV infection to reduce
viral reservoir size and delay or prevent HIV recrudescence is on the forefront of HIV curative science. However,
many current gene modification approaches focus solely on reducing CCR5 expression on hematopoietic stem
cells or mature CD4 T cells. These approaches may have limited impact in people with HIV (PWH) that have
virus able to use other coreceptors for entry, and only provide a single layer of protection against infection in
vivo. As a result, the AMC #097 study, “A Phase I Study of Stem Cell Gene Therapy for HIV Mediated by
Lentivector Transduced, Pre-Selected CD34+ Cells: A Trial of the AIDS Malignancy Consortium,” was
implemented to combine multiple anti-HIV genes into a single lentiviral vector that is designed to block HIV-1
infection at different stages of the HIV-1 life cycle providing strong pre-integration inhibition of HIV-1 infection
using a lentiviral vector that including a CCR5 shRNA, a chimeric human-macaqueTRIM5α restriction factor, and
a HIV TAR decoy. This strategy has been shown to prevent infection in vitro and in vivo, and 12 PWH requiring
autologous SCT for lymphoma have already received gene modified stem cells through AMC097. One participant
stopped ART outside study protocol following SCT and experienced post-treatment control. Whereas the primary
endpoints of the study are to evaluate the safety of such an approach, support is urgently needed to perform in-
depth HIV reservoir analyses and to implement assays to determine if gene modified cells become infected
following transplantation with or without analytical treatment interruption. We will: (1) test the hypothesis that
autologous SCT with gene modified stem cells simultaneously targeting different stages of the HIV-1 replication
cycle will lead to blood and gut tissue expansion and maintenance of a transduced CD4+ T and other immune
cells resistant to HIV-1 infection; (2) test the hypothesis that SCT with gene modified stem cells will reduce the
size of the HIV-1 reservoir and residual HIV-1 transcriptional activity, and lead to post-treatment HIV control
following withdrawal of ART, and (3) determine if gene modified cells become infected prior to and following
cessation of ART a novel duplexed single-cell-droplet (scdPCR) assay with the ability to simultaneously detect
cellular HIV-1 DNA or RNA and the integrated lentiviral vector or chimeric TRIM5α transcriptional activity.

Public health relevance
NARRATIVE This study will determine the impact of autologous SCT with gene modified stem cells simultaneously targeting different stages of the HIV life cycle on the size and activity of the HIV reservoir, and determine if gene modified cells become infected with HIV following cessation of antiretroviral therapy. Results from this study will have the potential to improve and direct future gene therapy studies for HIV cure.